Administrative Core

ABSTRACT
The Administrative Core is comprised of the Principal Investigator, Program Director, Director of
Administrative Services, Technical Writer and a Project Manager II and will be responsible for the
overall management of the proposed program. This Core will serve as the intermediate between
NIMHD, the University and components within the RCMI program. The specific aims of the Administrative
Core are to: 1) Provide leadership necessary for the planning, implementation and management of all program
activities consistent with achieving RCMI program goals and mission; 2) Provide administrative management
in areas of procurement, human resources and financial oversight; 3) Facilitate the implementation of all
operational activities, workshops and seminars under the research infrastructure, community engagement and
dissemination, research and pilot projects components; and 4) Serve as an intermediary between all
components of the RCMI program and NIMHD and all external constituents. The Administrative Core will
establish an Advisory Board and Steering Committee to oversee all aspects of the program and to
ensure that program objectives and specific aims are met. Board members will include members with
expertise in prostate cancer biology, health disparities, molecular biology of cancer, etc. The PI will be
responsible for the overall direction of the RCMI program and responsible for implementation of
programmatic objectives. The PD will manage the day-to-day administrative management of the
program while ensuring the coordination of all program activities. The Administrative team will work as
a team to execute all programmatic activities and implement these activities with continuous
consultation of the Advisory/Steering Committees. The RCMI program Administrative staff will provide
fiscal management of the program in regards to procurement services, pre- and post-budget
management, as well as establishing communications with other personnel in critical University offices,
i.e., Research and Sponsored Programs, Grants and Contract Accounting, Purchasing, etc. The
Administrative Core will also provide oversight and coordination of all activities within the research
infrastructure, community engagement core, research and pilot projects, career development activities,
and evaluation of program activities.

Public health relevance
Project Narrative – Administrative Core The Administrative Core will provide the overall management of the RCMI U54 program and serve as an intermediary between all components of the program, external constituents, and NIMHD.